Core A: Administrative/Biostatistics Core

CORE A ABSTRACT
Core A, the Program Management and Biostatistics Core, is directed by Multi-PIs Drs. Richard C.
Boucher and Michael Rubinstein and will have two major functions: 1) project coordination and
administration to achieve PPG goals; and 2) provision of statistical assistance in study design and
analysis. Oversight and assistance in guiding the overall scientific direction of the PPG will be
provided by an Internal Advisory Board, consisting of: Drs. Richard Superfine, Chair, Department
of Applied Sciences at UNC-CH; Dr. Greg Forest, Director, Carolina Center for Interdisciplinary
Applied Mathematics at UNC-CH; and Dr. Sam Lai, Director, Pharmacoengineering Program,
Division of Pharmacoengineering and Molecular Pharmaceutics at UNC-CH. Due to the nascent
status of the PPG, the External Advisory Board will be named later. The program management
functions of Core A will include: 1) budgetary and programmatic support; 2) facilitation of human
subjects interactions with the relevant IRBs with respect to human materials for airway
submucosal gland mucus studies; 3) conflict of interest management, with particular relevance to
agents obtained via MTAs; 4) personnel support, interfacing the PPG to the UNC human
resources departments; 5) manuscript preparation; 6) progress reports and correspondence with
the NHLBI; 7) information handling, including dissemination of all research data in an appropriate
and timely fashion; and 8) the coordination of a yearly External Advisory Board meeting. In
parallel, biostatistics consultation, design, and analyses will be performed by Ms. Agathe Ceppe,
who is a longstanding member of the Marsico Lung Institute as a provider of statistical services.
Finally, the Program Management and Biostatistics Core will oversee all issues of PD/PI
replacement designations, including those that may be relevant to the directorship of the PPG,
individual projects, or individual cores.